A Novel Approach Towards Hard Nail Tissue Regeneration

Contact PD/PI: Laurencin, Cato , T. Regenerative Engineering of Complex Musculoskeletal Tissues and Joints -- 1 DP1 AR068147-01 Over the past 20 years, the P.I. has performed substantial work in the development of engineered systems for the regeneration of musculoskeletal tissues. Systems inspired by his work in the area of bone and soft tissue have now been implanted in man. Now I will use the collective expertise and insight I have obtained to test a bold, new hypothesis that complex tissues and joints can be created and similarly find their way to clinical use in man. For this I will use principles of Regenerative Engineering, concepts recently published in Science, Translational Medicine that refer to the use of new advances in materials science, stem cell science and the understanding of cues from developmental biology in heuristic approaches toward complex tissue regeneration. I will explore integrating the individual component tissues developed via the regenerative engineering approach using expertise in developing matrix and cell-matrix constructs for engineering tissues. As the next step we will develop what I term integrated graft systems (IGS) such as osteochondral, osteoligamentous, muscle/tendon and vascularized tissues. Subsequent steps will examine the integration of peripheral nerve into the tissue systems and to develop additional component tissues. Cues are important. I will use experience in drug delivery and investigate the use of biological effector molecules such as the bone morphogenetic proteins as cues for differentiation. We have recently described a group of molecules we term inducerons—small molecule inducers of differentiation that may be particularly suited for musculoskeletal regeneration. Working with our collaborator, we will utilize cues from developmental biology, particularly limb regeneration as an important part of our work. Finally, we have gained substantial expertise in electrical/biomechanical cues for tissue regeneration. I believe we can utilize these cues for the generation of new functional joint tissues as well as integrated graft systems. The ultimate goal of the work is to use new insights in biomaterials including nanomaterials, stem cell technologies, and developmental biology, along with particular strength areas of the P.I., such as bioreactor based enhanced fluid and nutrient transport, to bring the possibility of whole limb regeneration to reality. While the P.I. has substantial experience in the area, the integration of tissues to the level this complex has never been performed, and represents quite a new direction for him. There is substantial risk in the research, as issues of adequate nutrient and oxygen transport to developing tissues, successful interfacial integration of constructs, and meeting functional requirements will need to be tackled. If successful however, this Pioneer Award Research project will usher in the new era of regenerative engineering, providing revolutionary clinical solutions to millions. Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: Laurencin, Cato , T. Statement of Public Health Relevance -- 1 DP1 AR068147-01 The problem of musculoskeletal tissue destruction, loss and wear has major societal implications. For example in the area of musculoskeletal joints, there are over 1 million total joint arthroplasty surgeries performed in the United States each year, with a rate of growth of 6% per year projected. Developing a new therapeutic strategy for the regeneration of complex musculoskeletal tissues and joints is proposed in this application. The work will revolutionize the way musculoskeletal tissue injury and wear is treated, tremendously improving the quality of lives of patients. Project Narrative Page 7